Promoting Smoking Cessation in Lung Cancer Screening through Proactive Treatment

Promoting smoking cessation in lung cancer screening through proactive therapy: PROACT
VA Medical Centers are beginning to offer eligible Veterans lung cancer screening following national
recommendations including the US Preventive Services Task Force's “B” recommendation for annual
screening. Preliminary evidence from the VA Lung Cancer Screening Demonstration Project suggests that
nearly 2.8 million Veterans will be eligible for screening and over half will be current smokers with a long
history of smoking. It is critical that offering screening to current smokers reinforces the importance of
cessation and does not reduce motivation to quit. Integrating cessation into lung cancer screening is
challenging, in part because of limited time and clinic resources, but also because of misperceptions about the
“protective” effect of screening among many current smokers. In the National Lung Screening Trial, primary
care providers offering screening adequately addressed smoking cessation with only 10% of current smokers.
This project will provide proactive behavioral and pharmacotherapy treatment to all current smokers as part of
participating in lung cancer screening. Tobacco treatment will be integrated with the reporting of screening
results. In our pilot study of the proactive telephone counseling component of the proposed intervention, we
increased participation in behavioral cessation treatment to 36% among intervention participants from 11%
among usual care control patients, and quit rates more than doubled to 18% in the intervention group.
Screening patients often report being motivated to participate in screening to find out how much smoking has
harmed them. Our proposed intervention is designed to convert this new level of patient engagement into an
opportunity to encourage cessation. Our proposed proactive care strategy removes the precondition of asking
patients if they are ready to quit. Over 14 trials have shown providing opt-out treatment to all current smokers
significantly increases quit rates.
We will conduct a pragmatic randomized trial with current smokers at VA Puget Sound and VA NY Harbor who
are participating in lung cancer screening. Patients will be randomized to receive either proactive care with opt-
out treatment accompanying their screening results (n=250) or usual care (n=250). Proactive treatment will be
arranged by a radiology-based coordinator, and will include a tailored results letter describing
pharmacotherapy, an appropriate prescription ordered in conjunction with the patient's primary care provider,
and two proactive telephone-based behavioral counseling sessions. The telephone counseling component will
be delivered by counselors at VA's national quitline. The primary endpoint is biochemically confirmed 7-day
abstinence 12 months after screening. Based on prior trials of opt-out treatment and our pilot data, the trial is
powered to detect an improvement in quit rates from 9% with usual care to at least 18% with opt-out treatment.

Public health relevance
Nicotine replacement treatment (NRT) doubles the chances of successfully quitting, especially when combined with behavioral counseling. However it remains underutilized in Veterans. Routinely providing proactive treatment that includes NRT to current smokers can increase its use and promote cessation. Lung cancer screening is a newly recommended clinical service that offers a fresh opportunity to engage smokers in education about cessation treatments. This project will implement and test a pragmatic workflow strategy for integrating proactive treatment into routine lung cancer screening processes.